FY25 TASK ORDER D - BASE: WO 126680 B539 EAST BASEMENT SWITCHBOARDREPLACEMENT. OPTION 1: 126680A B539 WEST ATTIC SWITCHBOARDREPLACEMENT

Base - The purpose of this project is to replace five aged switchboards in the East Basement of B539 with new code compliant switchboards. Additional work will be required to nearby utilities to ensure that the basement area for the new installation is code compliant.

Option 1 - The purpose of this project is to replace three aged switchboards in the West Attic of B539 with new code compliant switchboards. Additional work will be required to nearby utilities to ensure that the attic area for the new
installation is code compliant.